MEMBRANE CURRENTS IN CARDIAC MUSCLE

The long-term goal is to understand bow voltage-dependent ion channels produce the human cardiac action potential. The specific aims are to: 1) fully characterize three different inward rectifier K+ channels (IRKs) that we have identified in human heart (hhIRKs); 2) characterize an accessory subunit which may be associated with hhIRKs; 3) examine the effects of Class III antiarrhythmic drugs (AADs) on the newly identified hhIRKs; 4) determine whether naturally occurring, cytoplasmic polyamines are physiological blockers of hhlRKs; and 5) examine mechanisms of action of Class III AADs on voltage-dependent outward rectifier K+ channels (ORKs) cloned from human heart and interactions among ORKs, Class III AADs and a novel human heart ORK beta-subunit. The broad hypothesis being tested is that mechanistic studies of the effects of antiarrhythmic drugs can be performed directly on human cardiac ion channels rather than inferred from studies on non-human animals. The health relatedness of the project derives from two facts: cardiac arrhythmias are the main cause of death in the USA, and satisfactory antiarrhythmic therapy remains to be achieved. This research, therefore, sits at the interface between basic and clinical studies of cardiac electrophysiology. The research is focussed on K+ channels which are the primary targets for Class III antiarrhythmic drugs. In particular, new information is being accumulated concerning the complexity of the inward rectifier K + current IK1 which sets the resting potential of cardiomyocytes and is important for terminal repolarization of the cardiac action potential. The research design uses recombinant DNA methods to clone IRKs and ORKs from human heart tissue, to express the cloned channels stably or transiently in heterologous cells and to mutagenize the channels for aid in understanding the mechanistic actions of cardiac antiarrhythmic drugs. Electrophysiological methods are used to study the expressed ion channels and to compare their functional properties in heterologous cells to their properties when they are expressed in their native human cardiomyocyte environment.